PARALLEL IMAGE RECONSTRUCTION FOR 3-D POSITRON CT

A study on developing parallel processing schemes for -3-D positron computerized tomography (P-CT) is proposed. Computerized tomographic imaging techniques have played an important role in medicine since the early 1970's and are expected to become an inevitable diagnostic technique in the future. However, the long image reconstruction time has been one of the major drawbacks associated with the technique. The computational demand for future 3-D positron CT systems would be formidable due to the enormous amount of projection data and time-consuming reconstruction algorithm. It is well recognized that conventional sequential computer cannot provide such an enormous computing power. Therefore, employing multiple processing elements is inevitable to speed up reconstruction. The goal of this research is to develop efficient parallel computing architecture and algorithm dedicated to 3-D P-CT, which can reconstruct images from projection data fast enough for practical applications at a reasonable cost. CT image reconstruction consists of filtering and backprojection in an analytic algorithm, and estimation and correction, which basically have the similar computational structure to that of backprojection, in an iterative algorithm. It will be the first step in this project to identify potential parallelism within each part and among different parts of the algorithm. Then, a well-balanced multiprocessor system is to be designed to optimally exploit the parallelism with the efficient parallel reconstruction algorithms. Throughout the proposed study, great emphasis will be laid on achieving smooth data flow among processing elements.